Data and Biostatistics

The data and biostatistics core will be responsible for providing data management, information technology and biostatistical support to the research investigators of the proposed Tropical Medicine Center. Specifically, they will ensure data integrity and confidentiality for the three projects proposed, and will perform all data analyses related to these projects. This core has extensive experience conducting sophisticated analyses related to many different epidemiological studies with varying methodology. Furthermore, they are experienced in capacity building and one component of this Center will be local capacity building, specifically related to data entry, data cleaning and data analysis. The Core Head (Rahme), and two Key Personnel (Casapia and Gyorkos) are all University Profesors that teach in Departments of Epidemiology and Biostatistics. The remainder of the core is also qualified for capacity building. The highly qualified data and biostatistics core that we propose will be an essential component to the success of this Center. It will be crucial in generating the results ofthe three research projects and filling the current research gaps.

Public health relevance
The data and biostatistics core will be essential to achieving the primary goal of this Centre, to reduce morbidity associated with NTDs in the Americas. Proper statistical methods are crucial to answering any research question. In order to create appropriate recommendations and therby decrease morbidity associated with STH infection, the research gaps addressed in the proposed projects need to be answered. The data quality and statistical analyses are imperative o properly inform recommendations